Project 1: Optimizing Smoking Cessation Treatment in Primary Care: A Factorial Screening Experiment (Cessation Screening)

Project Summary
Tobacco use is the leading preventable cause of both premature deaths overall and cancer deaths in the US.
Most smokers visit a healthcare setting each year, providing an unequaled opportunity to intervene. Yet, most
smokers do not receive highly effective cessation treatment during their healthcare visits. To improve the
effectiveness of smoking treatment in healthcare, this project will identify especially promising medication
regimens and counseling modalities for use in primary care for the two most effective smoking cessation
pharmacotherapies: varenicline and combination nicotine replacement therapy (C-NRT). The criteria for
identifying promising varenicline and C-NRT treatments will include 1-year biochemically confirmed point-
prevalence abstinence and cost. Smokers (N=608) from primary care clinics, who want to quit smoking, will be
randomized to receive one of two levels of each of four factors: 1) Medication Type (Varenicline vs. C-NRT), 2)
Preparation Medication (4 weeks vs. Standard), 3) Medication Duration (Extended [24 weeks] vs. Standard [12
weeks]), and 4) Counseling Modality (In-Person vs. Phone). The proposed research builds on our expertise
and prior research findings to address a critical knowledge gap: i.e., how best to use the most effective
smoking cessation pharmacotherapies in real-world healthcare settings. This research will use an efficient and
innovative methodology (i.e., the Multiphase Optimization Strategy) to identify the most promising C-NRT and
varenicline-based treatments to use with primary care patients who smoke. These especially promising
(“optimized”) treatments will then be evaluated in a randomized clinical trial in the Optimized Care Project of
this Program Project.

Public health relevance
Project Narrative The proposed research will identify especially effective strategies to use with the two most effective smoking cessation pharmacotherapies: varenicline and combination nicotine replacement therapy, so they produce high levels of smoking abstinence at low cost. Identifying especially effective treatments using varenicline and combination nicotine replacement therapy could increase smoking cessation in primary care patients and thereby reduce the death and disease caused by tobacco.